The Trajectories and Clinical Experiences of ICD Therapy (TRACER-ICD) Study

Project Summary / Abstract X
Over 50,000 implantable cardioverter-defibrillators (ICDs) are implanted annually in patients ≥65 years old at an
estimated cost of >$2 billion. ICD guidelines draw upon trials enrolling few older patients, yet half of these patients
will either be dead or enrolled in hospice within 5 years of implantation. Though Medicare now mandates shared
decision-making (SDM) for ICDs, few studies have investigated questions vital for older patients, including health
status trajectories and quality of life. Improved SDM for older patients requires moving beyond average treatment
effect estimates to incorporate precision modeling of these outcomes. There is therefore a pressing need for
longitudinal data to support patient-centered SDM for older adults. To extend our prior work and further
improve SDM for older adults considering an ICD, we propose the TRAjectories and Clinical ExpeRiences
of ICD Therapy (TRACER-ICD) Study, a multi-center prospective cohort with the goal of better defining
patient-centered goals and experiences in older patients undergoing ICD implantation. We will
prospectively collect data on geriatric conditions and quality of life from patients at 5 sites, enriched with remote
monitoring data on arrhythmias and physical activity, to evaluate their clinical and functional trajectories (Aim 1).
This cohort will support further refinement of our statistical model to personalize prediction of treatment outcomes
(Aim 2). Lastly, we will use mixed methods to identify optimal implementation strategies for translating these
individualized prediction profiles into SDM for ICDs (Aim 3).This proposal is led by an Early Stage Investigator
whose expertise in cardiac electrophysiology, geriatric medicine, and outcomes research will be complemented
by an experienced research team with a strong record of collaboration.
IMPACT: As the first comprehensive, prospective study of older ICD patients, TRACER-ICD will generate
unique patient-centered and personalized data essential for characterizing outcomes of this common procedure
in a vulnerable population. Much like other large cohort studies in older persons, we anticipate the robust data
emerging from TRACER-ICD will serve as a rich resource that will improve care for millions of patients
considering ICD implantation, and provide essential, evidence-based guidance for translating personalized
outcome profiling into the SDM experience.

Public health relevance
Project Narrative X Implantable cardioverter-defibrillators (ICDs) are commonly used in older patients with multiple co-morbidities. This project will use a multi-center cohort study to prospectively define patient-centered experiences of older patients following ICD implantation. We then apply these data to the shared decision-making process with individualized decision tools, evaluating the feasibility of a precision approach to ICD use.